Examining Contributors to Disparities in Gender Affirmation and Mental Health among Black and Latinx Transgender Youth

Project Summary/Abstract
This is an application for a K23 award for Dr. Stanley Vance, Jr., MD, whose research focuses on
barriers to gender-affirming care for transgender youth. His research training includes an Adolescent Medicine
fellowship and formal course work in quantitative approaches. Through activities proposed in this application,
Dr. Vance will build skills in qualitative methodology, youth/caregiver-facing intervention development, and
randomized controlled trials. The resources to foster his career development include UCSF’s Adolescent and
Young Adult Medicine Division, Child and Adolescent Gender Center, Center for AIDS Prevention Studies, K-
Scholars Program, and graduate coursework in qualitative methods and intervention development and trials.
He has convened a mentoring team experienced in relevant disciplines of community-based research with
transgender populations, pediatric transgender research, qualitative methods, and intervention implementation
to guide the completion of his research and career development into an independent researcher.
Informed by the Gender Affirmation and Intersectional Stigma models, this proposal focuses on Black
and Latinx transgender youth (BLTY). BLTY face intersecting forces of racism and transphobia, thereby
increasing their vulnerability to poor mental health outcomes. However, there is a paucity of data that
document the cultural and familial factors that may contribute to these mental health disparities. Although
gender affirmation—receiving social support for one’s gender identity and/or medical treatment to affirm one’s
gender—improves mental health for transgender youth, cultural and parental influences on gender affirmation
for BLTY have not been delineated. Exploring such factors could provide critical information to supporting
BLTY and their caregivers through interventions. This career development award seeks to address these gaps
in the literature through the following specific aims which will be carried out with guidance from a Community
Advisory Board: Aim 1: To gather qualitative data to inform the development of a culturally informed
intervention to improve mental health outcomes among BLTY. This includes conducting in-depth interviews
with Black and Latinx transgender young adults about their prior experiences with gender affirmation and how
their caregivers and cultures influenced such experiences. This aim also includes focus groups with Black and
Latinx caregivers to understand cultural views of gender diversity. Aim 2: To develop a culturally informed
intervention that promotes gender affirmation and mental health of BLTY. An intervention informant group with
BLTY and caregivers will provide direct input into the development of a culturally informed intervention. Aim 3:
To pilot test the intervention via a randomized controlled trial. The intervention and control condition will be
administered to BLTY and their caregivers to evaluate the intervention’s acceptability, feasibility, and
preliminary efficacy on mental health symptoms. At the conclusion of this award, Dr. Vance will apply his
findings to develop an R-level grant application for a larger RCT of the developed intervention.

Public health relevance
Project Narrative Provision of equitable care and support to Black and Latinx transgender youth and their caregivers is a crucial step in addressing the poor psychosocial outcomes experienced by Black and Latinx transgender persons in adulthood that include depression, substance abuse, and suicidality. The proposed plan will help answer questions about how to optimally support Black and Latinx transgender youth. Findings from the proposed plan will be relevant to the academic and public health arenas and ultimately further the field of pediatric transgender medicine in addressing racial disparities in mental health outcomes and gender affirmation.